Applying Neuromodulation to Boost the Efficacy of Motivational Interviewing

The use of cannabis and alcohol is associated with myriad health consequences
including motor vehicle crashes, myocardial infarction, and cancer risk. For example,
alcohol accounts for nearly a third of head and neck cancers. Despite this, few adults
with a substance use disorder (SUD) receive any form of treatment. When adults with
an SUD do receive behavioral treatment, they typically receive only a single session.
Given this, it is essential to make that one session count. There is a clear need for
adjuncts to treatment for people who have an SUD.
One potential way to boost the efficacy of treatment is non-invasive brain stimulation
such as transcranial alternating current stimulation (tACS), which involves administering
small electrical currents through scalp electrodes. tACS delivers sinusoidal currents
similar to those produced by intrinsic neuronal oscillations – that is, brain rhythms.
Because of this, tACS can be used to enhance a given brain rhythm.
This is important because brain rhythms mediate a broad range of brain functions,
including processing of sensory stimuli, attention, memory and the generation of motor
output, as well as to contribute to activity-induced synaptic plasticity. They also play a
causal role in linking distributed brain regions into functional networks. Testing the
causal effects of neuronal oscillations in SUD using tACS could mark a significant step
forward for SUD research and treatment.
Our pilot data suggest that within motivational interviewing (MI) treatment sessions, brain
rhythms in the beta frequency band (15-25 Hz) are stronger during client statements
supporting behavior change (“change talk”) than during client statements supporting the
status quo (“sustain talk”). A large body of research in MI indicates that the quantity of
the client’s change and sustain talk during their intervention session is related to their
SUD outcomes. Our data suggest that using tACS to enhance beta band brain rhythms
may boost the effects of client change talk and reduce those of client sustain talk.
Therefore, in the UG3 phase we propose to test the effects of an MI and tACS
intervention in a randomized trial to modulate change talk and oscillatory brain activity. In
the UH3 phase, we will test the effects of the MI and tACS intervention on brain
functional networks and substance use outcomes. If successful, this UG3-UH3 phased
innovation study will provide a new and accessible means of boosting the efficacy of
motivational interviewing, improving outcomes for people with a substance use disorder.

Public health relevance
This study will show us whether non-invasive brain stimulation affects the speech and brain activity of people during treatment for substance use disorder, and whether it also improves treatment outcomes for people with a substance use disorder. It will also help us to understand exactly which processes are affected by the brain stimulation, and how the brain stimulation works to change substance use.